Administrative Core

The Administration Core (Core A) will have primary responsibility for overall scientific and financial
management of the P01. The overall mission of this P01 is to assemble a comprehensive program that integrates
bioinformatic and genomic expertise to enable not only identification of disease-causing variants in individuals
with SCID and T cell deficiencies, but also to exploit genome editing as a truly personalized approach to
treatment. The P01will have three research Projects: Project 1,Systematic identification of candidate
disease-causing variants in patients with T cell insufficiency; Project 2. Genome editing to create,
validate and correct allelic variants responsible for T cell insufficiency; and Project 3, Functional analysis
of allelic variants responsible for T cell insufficiency. These will be complemented by three Cores (including
this one): Core A, Administration; Core B, Informatics Infrastructure and Bioinformatics Analysis; and
Core C, Participant Enrollment and Sample Management. The Administration Core will meet its
responsibility by implementing four specific aims: 1) Provide strong scientific leadership; 2) Provide
administrative support; 3) Provide fiscal oversight and management of all P01 activities; and 4) Facilitate all
planning and evaluation activities for the P01. This work will ensure effective progress, optimal utilization of
resources, and enhancement of the synergies among P01 investigators and Projects. The Administration Core
includes a Steering Committee consisting the Co-Principal Investigators and the Project and Core Leads, which
will be responsible for reviewing progress and making major decisions, and will be based at the University of
California, San Francisco (UCSF).